RANDOMIZED COMPARATIVE TRIAL OF ZDV VS DDI VS ZDV PLUS DDI IN HIV

A multicenter randomized double blind comparative trial of ZDV vs. ddI vs. ZDV plus ddI in HIV infected infants and children without prior antiretroural therapy.